Modeling and prediction of allergic trajectories in children

PROJECT SUMMARY/ABSTRACT
I seek to become an independent, NIH-funded academic allergist-immunologist and clinical research informatician
invested in improving outcomes in pediatric allergy. To this end, I will utilize electronic health record (EHR) data to study
developmental patterns of pediatric allergic diseases and harness this knowledge to develop clinically relevant allergy prediction
models using artificial intelligence approaches. I am in my final year of fellowship in pediatric allergy-immunology at the
Children’s Hospital of Philadelphia (CHOP) having completed MD-PhD and pediatric residency training. I possess a strong
background in experimental and clinical immunology and have pivoted to clinical research informatics for my post-doctoral
research work, as it is aligned with my long-term career goals. Despite my development of multidisciplinary collaborations that
have led to several publications, I require dedicated training in bioinformatics, statistics, and epidemiology in order to successfully
conduct research independently in this space. The K08 Mentored Clinical Scientist Development Award is the optimal means by
which I can obtain this additional experience and training. My training plan includes formal coursework through certificate
programs at Penn. I will complement this with hands-on training with an exceptional team of mentors (Dr. David Hill, primary
mentor; Dr. Robert Grundmeier and Dr. Rich Tsui, co-mentors) and advisors (Dr. Alex Fiks, Dr. Jonathan Spergel, and Dr. John
Holmes). My training will also greatly benefit from the first-rate clinical and research environments at CHOP/Penn.
To complement my training plan, I have developed an integrated research proposal that will allow me to model the
development of allergic diseases in children. There is considerable variability from child to child in the sequence and number of
allergic conditions that they develop, an emerging concept in the allergy field termed allergic trajectories. The basis for these
heterogeneous allergic trajectories is incompletely understood. To date, allergy epidemiology has been measured largely via
patient questionnaires, which are susceptible to reporting and self-selection biases. EHR databases contain demographic and
longitudinal clinical data and thus represent an alternative approach for the study of allergic disease risk factors; however, they
have been scarcely used for the study of their trajectories and for the development of disease risk prediction models. Building on
my published and preliminary work, I will use the multi-institutional Comparative Effectiveness Research through Collaborative
Electronic Reporting (CER2) and CHOP primary care network EHR databases to test the hypothesis that heterogenous allergic
trajectories exist that are differentially associated with specific clinical, demographic, and/or environmental factors. The aims of
my study are (1) to determine the major pediatric allergic trajectories and their biologic and non-biologic risk modifiers using
multivariable logistic regression and Cox proportional hazards testing and (2) to develop and test EHR-based allergy risk
prediction models that consider clinical and demographic information using machine learning and exploratory natural language
processing. Study results will be externally validated in the independent, multi-institutional PEDSnet database. This work will
yield clinically relevant tools that are expected to inform personalized medicine efforts focused on preventing and predicting
pediatric allergy. By completing the proposed research and career development plans, I will be well positioned to function as an
independent physician-scientist investigator at the intersection of pediatric allergy-immunology and clinical research informatics.

Public health relevance
PROJECT NARRATIVE Though allergies are among the most common chronic diseases of childhood, we have a poor understanding of why some children develop specific allergic conditions while others do not. This proposal will utilize multi-institutional electronic health record data and advanced statistics, machine learning, and natural language processing approaches to identify factors influencing allergic outcomes and to develop risk prediction models to assist with clinical management. In the age of personalized medicine, this research will help guide efforts to predict and prevent allergic diseases in children.